Comprehensive Analysis and Multi-Omics Data Integration for Cancer-Related Studies

Project Summary/Abstract
I am a Research Associate and Bioinformatics Manager of The Experimental and
Computational Genomics Core in the Sidney Kimmel Comprehensive Cancer Center
(ECGC) at Johns Hopkins University. This Core offers comprehensive bioinformatics
support to members of both the Cancer Center and the Bloomberg~Kimmel Institute for
Cancer Immunotherapy (BKI), including both standard informatics and innovative
analysis pipeline development. To this work, I bring expertise in genomics data analysis
methods through my role leading the DNA methylation analysis in several tumor types
for The Cancer Genome Atlas (TCGA). In my role as Bioinformatics Manager of ECGC,
I oversee day-to-day bioinformatics services and supports the bioinformatics needs of
investigators in areas of data integration, annotation, and high-throughput data analysis.
In this capacity, I develop bioinformatics software tools to support many cancer
research activities. I collaborate with a number of investigators across both the cancer
center and BKI. I highlight three key collaborations in this application as illustrative of
my research portfolio. For example, (1) I played a key role in the comprehensive
analysis of T-cell receptor sequencing data for the FEST (Functional Expansion of
Specific T cells, http://www.stat-apps.onc.jhmi.edu/FEST/) assay. (2) I perform
integrative analysis of multiplex data to find better biomarkers to predict response to
cancer immunotherapy using both expression of immune markers in addition to density
and a spatial correlation of cells expressing those makers. (3) I am lead analyses for
basic tumor biology to determine how chromatin structure is associated with gene
expression and alternative splicing. With the support of this R50 award, I will extend my
current pipeline development to state of the art single cell measurement technologies
and data integration techniques and train future bioinformatics analysts to benefit
various cancer-related studies throughout the cancer center and BKI.

Public health relevance
Project Narrative Comprehensive bioinformatics analysis and multi-omics data integration is an essential part of a wide variety of cancer-related studies such as biomarker discovery for cancer immunotherapy or the role of epigenetics in cancer-specific regulation. This application is aimed to support the development of state of the art bioinformatics analysis pipelines through my role as Research Associate and Bioinformatics Manager of The Experimental and Computational Genomics Core in the Sidney Kimmel Comprehensive Cancer Center. The support of the R50 award will enable broader access of comprehensive bioinformatics expertise provided by the Experimental and Computational Genomics Core for diverse cancer-related studies by members of both the Sidney Kimmel Comprehensive Cancer Center and the Bloomberg~Kimmel Institute for Cancer Immunotherapy at Johns Hopkins.